INTERACTION OF INDOMETHACIN AND LOSARTAN IN HYPERTENSION

This study is designed to determine whether taking indomethacin at the same time as losartan 50 mg once daily or captopril 50 mg twice daily interferes with the blood-pressure lowering effects of these drugs. Losartan and captopril are blood pressure lowering drugs, indomethacin is a drug that relieves pain and reduces swelling.